HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS)

Despite a wide-ranging interest in performing clinical research for bioelectronic medicine applications, there are
no available open-architecture and open-source implantable systems for autonomic nerve stimulation and
recording. As a result, clinical researchers face significant technical, regulatory, and financial hurdles in getting
access to the implantable neuromodulation technologies that are required for performing these clinical studies.
There are several clinical closed-loop implantable neuromodulation systems presently available and they have
been helpful in supporting clinical research. However, in their current form, none are suitable for the bioelectronic
medicine applications, as they lack key modules for accessing the autonomic nerves; moreover, many of them
use closed architectures.
To address this challenge, we propose to develop the mechanical modules for the implantable pulse
generator (IPG) platform and external charger, which will be based on a flexible, open-architecture, and modular
approach. Such flexibility will allow a significant degree of customization for different clinical indications,
including open-loop and closed-loop IPG operation. The IPG modules will be designed for interfacing with a
large selection of sensing and stimulation leads. Once the IPG and charger modules are developed, they will
be subjected to the benchtop mechanical testing.

Public health relevance
Not applicable per solicitation. Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRAsystems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.